Clinical Support Services

The Intramural Laboratory of Clinical Investigations (LCI) provides support for the research and administrative infrastructure of all NCCIH clinical protocols. The support provided are either general services provided to the NCCIH intramural clinical program as a whole or clinical research support services that could not be assigned to other more specialized project The services provided are (1) physician and nurse-practitioner coverage of patients admitted to the CRC, as well as some patients in outpatient clinics; (2) research nursing support for clinical protocols; (3) support for the preparation and submission of clinical protocols to the Institutional Review Board (IRB); (4) database support for clinical protocols; (5) credentialing; (6) general secretarial support; and (6) scheduling of appointments.

The clinical protocols supported are:
16-AT-0077 Phenotyping Protocol
19-AT-0089 Afferents for Deep Pressure
15-AT-0132 Mechanisms of pain
16-AT-0136 Ear stimulation, pain and mood
17-AT-0155 Pain Expression & Assessment
17AT0075 Affective touch (data analysis)
10ATN072 NCCIH Repository Protocol (data analysis only)